Clinical Support Services for the NIAMS Intramural Research Program

This project has provided research infrastructure support for the following clinical protocols as noted: 03-AR-0173: Studies of the Natural History, Pathogenesis and Outcome in Autoimmune and Inflammatory Diseases Including Juvenile Dermatomyositis 11-AR-0223: Studies on the Natural History and Pathogenesis of Spondyloarthritis 12-AR-8001: Compassionate Use Treatment Protocol 14V-MC-JAGA Treatment of Autoinflammatory Syndromes Expected to Benefit from JAK 1/2 Inhibition 18-AR-0081: Investigation of the Natural History, Genetics and Pathophysiology of Systemic Juvenile Idiopathic Arthritis and Adult-onset Still's Disease and Related Inflammatory Conditions 91-AR-0196: Studies on the Natural History and Pathogenesis of Polymyositis, Dermatomyositis, and Related Diseases 00-AR-0222: Studies of the Pathogenesis and Natural History of Arthritis and Related Conditions 01-AR-0227: Natural History of Rheumatic Disease in Minority Communities 14-AR-0200: Studies of the Natural History, Pathogenesis and Outcome of Idiopathic Systemic Vasculitis 15-AR-0165: Study of the Natural History, Pathogenesis and Outcome of Melorheostosis-a Rare Osteosclerotic Disease 07-AR-0146: Analysis of Stored Identified Specimens from Patients Enrolled in Protocol Number 98-AR-0150 99-AR-0004: Molecular Basis of Primary Immunodeficiencies 15-AR-0185: Safety of Tofacitinib, an Oral Janus Kinase Inhibitor, in Systemic Lupus Erythematosus; a Phase Ib Clinical Trial and Associated Mechanistic Studies 15-AR-0060: The Role of PPAR-gamma Agonists in Immunomodulation and Vascular Prevention in SLE (PPAR-SLE). 94-AR-0066: Studies of the Pathogenesis and Natural History of Systemic Lupus Erythematosus (SLE) 03-AR-0131: Genetic Determinants of Ankylosing Spondylitis Severity - Longitudinal Study 04-AR-0205: Progression of Spinal Fusion in Ankylosing Spondylitis 13-AR-0056: Stopping Anti-TNF Agents in Rheumatoid Arthritis (STARA) Trial 15-AR-N010: Frequency and Complications of Major Orthopedic Procedures in Medicare Beneficiaries 96-AR-0102: Standard Care Dermatology; Evaluation and treatment of subjects with dermatologic diseases 18-AR-0035: Topical ruxolitinib in cGVHD; Phase II study of topical ruxolitinib for cutaneious chronic graft versus host disease (cGVHD) 13-AR-0071: Anakinra in Pustular Dermatoses; A phase 2 study of anakinra in inflammatory pustular dermatoses: evaluation of therapeutic efficacy and validation of pathogenic mechanisms 20-AR-0046: Phase 2 Zilucoplan in IMNM (Andrew Mammen); A phase 2, multicenter, randomized, double-blind, placebo-controlled study to evaluate the safety, tolerability, and efficacy of Zilucoplan in subjects with immune-mediated necrotizing myopathy 000207: SAD-COVID: The natural history of coronavirus disease (COVID-19) in systemic autoimmune diseases; an observational prospective study 20-AR-0032: Glucocorticoid Genomics in SLE; Genomic effects of glucocorticoids in patients with systemic lupus erythematosus 13-AR-0005: STOP LUPUS: A phase 1b, randomized, double-blind, placebo controlled study with an open label extension to evaluate the safety and tolerability of Omalizumab, a humanized IgG1 monoclonal antibody in patients with lupus (STOP LUPUS)